PERIMENOPAUSE AND GLIAL INFLAMMATORY RESPONSES THAT INTERACT WITH NEURON AGING

Alzheimer disease (AD) involves inflammatory processes at many levels. Because ovarian steroids show many anti-inflammatory activities, hormone therapy (HT) in AD may involve inflammatory pathways activated during the menopause transitions when hormonal deficits emerge progressively. We propose rodent models of perimenopausal stages to analyze inflammatory changes in brain regions vulnerable to AD, with a focus on aging Sprague-Dawley rats. The 3xTg-AD mouse model will be used to examine specific hypothesis about relationships of inflammation during aging to human familial AD. These models will be examined for responsiveness to HT, according to the KEEPS clinical model of E2 + cyclic P4. We will examine E2-P4 effects on microglial-astrocyte interacfions in inflammation and in neurotrophic effects. Specific Aim 1: Inflammatory profile in rat and mouse models of human perimenopause and menopause stages (Animal Core B). 1.1. Inflammatory gene expression and bioinformatics analysis in hippocampus and cerebral cortex of aging rats and mice from different menopausal stages (Analytic Core). 1.2. In vitro modeling of perimenopausal inflammatory changes, using primary glial cultures originated from perimenopausal rats. 1.3. Bioenergetics of glia cultured from perimenopausal rats (with Project 1). Specific Aim 2: Neurodegenerative mechanisms in perimenopausal inflammatory changes, using glial- neuronal co-cultures. 2.1. Role of inflammatory genes in glial-mediated neuronal support. 2.2, Role of estrogen receptors (ERa:ER|3) in regulating perimenopausal glial inflammatory phenotypes. Astrocytes from aging rats are deficient in neurotrophic support, in which one factor is altered ratio of estrogen receptors ERa:ERp (pilot data). 2.3. Role of progesterone receptors (PR) in regulating perimenopausal glial inflammatory changes, with a focus on Pgmrc1 (pilot data). 2.4. Role of glial N0S2 in neuronal mitochondria dysfunction (with Project 1). 2.5. Obesity-inflammation interactions (with Project 3). Specific Aim 3: Effects of perimenopausal HT on brain cell inflammation. Following the KEEPS model of E2 + cyclic P4, rats and 3xTg-AD mice will be given HT during perimenopausal cycling stages. 3.1. Inflammatory gene expression and bioinformatics (Analytic Core). 3.2. In vitro models of inflammatory changes, using primary glial from aging rat cerebral cortex. 3.3. Bioenergetics of glial cultures (with Project 1).

Public health relevance
RELEVANCE (See instructions): Our primary goal is to develop animal models for the perimenopause transition to analyze brain cell sensitivity to ovarian steroids. Findings are relevant to optimization of hormone therapy to protect against normal age-related cognitive decline, multi-infarct dementia and Alzheimers Disease